Patient-Centered Approach for Treatment Decisions in Mitral Valve Prolapse

Project Summary/Abstract
Transcatheter edge-to-edge repair (TEER) has transformed the management of patients with degenerative
mitral regurgitation (MR). The Cardiothoracic Surgical Trials Network (CTSN) developed the Percutaneous or
Surgical Repair In Mitral Prolapse And Regurgitation for ≥65 Year-olds (PRIMARY) trial to study the
comparative effectiveness of mitral valve repair (MVR) versus TEER. However, decision aids (DAs) are
needed to integrate clinical evidence with patients’ values and preferences to allow them to make informed
treatment decisions.
Currently, no established DAs exist for patients with degenerative MR even though the Centers for Medicare
and Medicaid Services and many cardiovascular professional organizations highlight the importance of shared
decision-making (SDM). Several obstacles exist toward implementing SDM in clinical practice including the fact
that DAs are often developed long after a trial is published, making it challenging to immediately integrate
pivotal trial results into clinical workflows.
In this proposal, we will conduct a mixed methods study to elicit from patients and providers what outcomes
are most important to them so that in the future we can model the heterogeneity in treatment effect using data
from PRIMARY to create patient-centered DAs. This proposal will also study the barriers and facilitators toward
the use of SDM among key stakeholders in local Heart Teams.
Specific Aim 1: Identify outcomes most important to patients with severe degenerative MR considering
TEER or MVR. We will conduct qualitative focus groups among patients with severe degenerative MR to elicit
the range of outcomes patients consider important when selecting treatment options. Using these data and the
components of the PRIMARY composite endpoint, we will then create and administer a quantitative allocation
task survey to characterize how patients with severe MR prioritize outcomes when making treatment decisions.
Specific Aim 2: Identify outcomes most important to healthcare providers (HCPs) in recommending
TEER or MVR. We will conduct qualitative focus groups among cardiac surgeons, referring cardiologists,
interventional cardiologists, and nurses involved in the care of patients with degenerative MR to characterize
outcomes important to HCPs. We will then use these data to create and administer a quantitative point
allocation survey to characterize how HCPs prioritize outcomes.
Specific Aim 3: Identify barriers and facilitators to implementing SDM in mitral valve Heart Teams. We
will evaluate the process of introducing SDM into local Heart Teams by conducting qualitative interviews with
HCP stakeholders. These data will be used to map workflows and identify the optimal timing and process as
well as barriers and facilitators to integrating SDM in clinical practice.

Public health relevance
Project Narrative There are both surgical and transcatheter options for correcting mitral valve regurgitation in patients with mitral valve prolapse. Decision aids are needed to integrate clinical evidence with patients’ values and preferences to allow them to make informed treatment decisions. This proposal will identify outcomes most important to patients and providers in treating mitral valve prolapse through qualitative focus groups and quantitative surveys and will also identify barriers and facilitators to implementing shared decision making within mitral valve Heart Teams.